Amazonian Center of Excellence in Malaria Research

Abstract
The Administrative Core for the Amazonia ICEMR will provide infrastructure for overseeing all functions of
the Center activities. A key emphasis of Core A is to ensure seamless communications among the Projects
and the Biostatistics/Data Management Core B, with other ICEMRs, and with NIAID Program Staff.
The Administrative Core will coordinate the three Scientific Projects with the Data Management and
Biostatistics Core (Core B), providing a cohesive and synergizing structure to ensure that the Amazonia
ICEMR activities maximize the scientific impact of the ICEMR program. The Core A Director will provide
scientific and administrative leadership to enable and maximize program organization that promotes cross-
discipline interactions among all of the Research Projects and the Core B. Core A will therefore provide
scientific oversight combined with efficient, transparent and compliant administrative governance (human
subjects, animal subjects, biohazards, resource sharing) with regard to fiscal and resource management of
NIH-provided funds. This core will be based at the University of California, San Diego in the offices of ICEMR
Program Director, Dr. Joseph Vinetz. UCSD will administer the grant itself and carry out subcontracting with all
participating institutions according to NIH and University of California auditing standards. UCSD will be
responsible for purchase of major equipment and shipment to Shared Laboratory Resource Core at
Universidad Peruana Cayetano Heredia, and will make other purchases on behalf of the Projects and Cores if
pricing is advantageous.
These goals will be accomplished through the following Specific Aims: 1) To promote collaboration and
coordination among ICEMR key personnel through optimized communications; 2)To organize communications
with other network ICEMRs and with NIAID program staff to optimize collaboration and coordination of
activities and projects including periodic meetings and conference calls; 3) To coordinate fiscal management,
subcontracting, ordering and shipping of supplies for projects and the Data Management and Biostatistics
Core B; 4) To coordinate logistics of the Scientific Advisory Group, including lodging, travel and venue; 5) In
coordination with NIH program staff, to organize an annual network meeting and coordinate travel logistics
for Amazonia ICEMR participants; 6) To coordinate all administrative aspects of the Special Projects; To
coordinate, supervise and maintain all Human Subjects Protections protocols and approvals, biohazards
certifications, and vertebrate animal protections, protocols and approvals; 8) To coordinate reports of all
Project and Core Leaders for annual, non-competing renewals and preparation/reporting of interim and
annual Scientific Advisory Group meetings; and 9) To support research capacity building in the Amazonia
ICEMR to contribute to advance the Center’s integration.